EFFECT OF UREMIA AND ACIDOSIS ON INSULIN INDUCED PROTEIN ANABOLISM

The goal of the study is to quantitate the effect of insulin on protein degradation, amino acid oxidation and rate of protein synthesis in patients with chronic renal failure.